Giving and Taking Away: Mapping Ethical Recommendations for Addressing Emotional Retraumatization in Bionics Research

ABSTRACT
As investigations into emerging bionic technologies continue, it is imperative to understand and transparently
inform potential research participants and future patients about the risks and possible side effects of bionic
interventions. This transdisciplinary study combines methods from empirical bioethics and cognitive bionics to
achieve two overarching goals. The first will be to document potential risks of retraumatization of research
participants in bionic research that restores an embodied experience, changes it, or removes it. Thus, allowing
investigational bionic technology researchers to anticipate and plan for ethical approaches in the future that can
be outlined in the informed consent processes. The second, will establish standards for evaluating, disclosing,
and mitigating intended and unintended effects of perceptual modulation to guide informed consent for bionic
research and clinical interventions. The development of standards for ethically appropriate disclosure of intended
and unintended effects and psychosocial risks associated with use of cognitive bionic technologies will be
informed by stakeholders in biotechnology research. Stakeholders include those with lived experience
participating in bionic device research and experts in biomedical engineering, clinical translational research,
bioethics, research oversight specialists, and statistics. In connection with the objective to address ethical issues
pertaining to informed consent practices, the proposed project elicits participant perspectives on the informed
consent process in research into emerging biotechnologies and guides risk/benefit analyses to strengthen
informed consent practices for bionic device research. Ultimately, this research will provide practical guidance
to biotechnology developers, sponsors, and research oversight bodies regarding ethically optimal approaches
to informing prospective bionic research participants and future users of bionic technologies about implications
for user well-being.

Public health relevance
PROJECT NARRATIVE This research will establish new processes and standards for helping to address unexpected psychological or emotional harms, such as retraumatization, that can be experienced by people using advanced bionic technologies that merge with their basic sense of self. Beginning to identify currently unknown, but potentially foreseeable, negative responses will help generate foundational knowledge to support researchers in developing ethically optimal informed consent processes for research participants and future clinical users of bionic technologies.